Expanding support and training for new users of next-generation electrophysiology probes

Project Summary: Over the past decade, the capacity of electrophysiology has risen 5-10X driven in large
part by the introduction of Neuropixels 1.0 in 2017. The addition of the smaller 384 channel Neuropixels 2.0
probe in 2023 enables facile chronic use, 2 probes with the head stage weighs less than 1.3 grams. The
pending introduction of the 1536 channel probe Neuropixels 2.0 QuadBase in Q2 2024 followed by the
Neuropixels 2.0 size 1536 channels Neuropixels NXT Probe (developed entirely with support from NIH U01
NS115587) will add to the more than 1200 labs using Neuropixels. All these probes are sold by the fabricator,
imec, at cost with no support. To date the principal support channels have been the Neuropixels Slack
channel, once annual classes through an expired Wellcome Trust grant at University College London and an
expiring U24 at the Allen Institute (U24 NS109043). The development consortium for Neuropixels 1.0 and 2.0
do an annual survey to understand community needs. The leading request from this survey is more classes.
This application will provide at least 4 classes per year for at least 12 students per class.
The classes with emphasize hands on experience and practice, with the object that the students have enough
experience to return to their home labs with the knowledge to setup and record from live animals with
Neuropixels and analyze the data they produce. The class will not teach rodent surgery, but a demonstration of
chronic implants will be offered for at least once per year. The advent of pinpoint surgery planning, now
integrated into SpikeGLX and OpenEphys recording software will regularize and speed multiprobe insertion
experiments.
Equally critical to data generation, relatively simple once the anxiety for handling Neuropixels probes is
contained, is data digestion and interpretation. A simple two probe Neuropixels NXT recording will generate
nearly a 1 TB (terabyte)/hour. Digestion and understanding of such large data sets require a fundamental shift
in data management and information extraction. This process will be in hand by the teaching labs but will
evolve quickly over the timeline of this application. Students will analyze data they generate during the class.
We will evolve the content of this segment of our course as the methods and tools evolve over the 5 years.
More than one of the host labs maintains activity in data analysis pipeline creation and spike sorting evaluation
This project will provide support for the Neuropixels Slack channel (current users number ~4,400) and a suite
of online free instructional videos for all the Neuropixels systems including the OneBox recording system
expected in Q2, 2024. All lectures will be archived for online viewing on the NeuropixelsCentral YouTube
channel. Critical for a 5 year timeline in a space evolving as fast as high channel electrophysiology will be to
evolve the course content and recruit instructors at the forefront of the subject. That the host groups are large
volume Neuropixels users will ensure content remains current.

Public health relevance
Project Narrative: Neuropixels have become a dominant technology with more than user 1200 labs, but these probes are sold by their fabricator at cost with no support. The 2023 introduction of 4 shank Neuropixels 2.0 and the expected early access to the NIH funded 1536 channel Neuropixels NXT and the continued growth of the user community demand a formalized support including hands on courses.